How Hedgehog Contributes to Centrally Mediated Energy Homeostasis?

PROJECT SUMMARY
Obesity contributes to heart disease and diabetes, leading to early mortality. Two-thirds of adults in the United
States are overweight, adding to healthcare costs. Yet, energy homeostasis is not fully understood. Recent
research has revealed that primary cilia on neurons in the brain play a crucial role in preventing overeating and
obesity. Primary cilia are solitary, microtubule-based appendages found on most cell types.
These cilia are critical for specific cell-to-cell communication processes, with Hedgehog (HH) signaling
being one of the best-understood cilia-mediated pathways. HH is essential for tissue patterning during embryonic
development. Interestingly, we discovered that the components of the HH pathway are also present in the adult
hypothalamus, and their activity is influenced by feeding status and body composition. Activation of HH signaling
in specific neurons leads to hyperphagia and obesity. Thus, HH signals are redeployed after embryonic
development and influence adult feeding behavior.
First, we seek to build on these insights by determining how HH signaling in the adult hypothalamus
controls long-term energy homeostasis. We will identify the sources of HH ligands and the responsive cells within
the adult hypothalamus and test whether HH acts acutely to affect neuronal electrophysiological activity critical
to controlling feeding behavior.
Second, as HH signals can control the ciliary function of a G protein-coupled receptor (GPCR) during
development, we hypothesize that HH signals also regulate the function of ciliary GPCRs in neurons involved in
adult energy homeostasis. Therefore, we will test whether HH signals control neuronal signaling by MC4R and
MCHR1, two ciliary GPCRs involved in energy homeostasis.
Both HH signaling and ciliary GPCRs regulate protein kinase A (PKA). Thus, we will also test whether
neurons integrate HH signaling and ciliary GPCR output at the level of PKA. We test these hypotheses using
complementary in vitro and in vivo studies and both genetic and pharmacological approaches. Together, the
experiments involved in this project will reveal how ciliary HH signaling controls adult neuronal activity to regulate
long-term energy homeostasis.

Public health relevance
PROJECT NARRATIVE Obesity is an important health concern. This project builds on our expertise and established collaborations to learn how a process involved in embryonic development also plays a critical role in adult energy homeostasis. Better understanding of feeding behavior and energy homeostasis will lead to better treatments for human obesity.